Method Development/Validation In Microbiology

Project Summary The Kansas Department of Agriculture Laboratory aims to help create a national, fully integrated food safety system by expanding our testing capabilities in both Microbiology and Chemistry as well as increase sample throughput in both human and animal product testing. The Laboratory serves as the primary servicing lab for the Food Safety and Lodging (FSL) and Dairy and Feed Safety (DSF) programs. In this analytical track, KDAL will successfully verify existing FDA BAM Chapter 19b: Molecular Detection of Cyclospora cayetanensis in Fresh Produce Using Real-Time PCR. In future years, KDAL will continue testing Cyclospora in produce samples. Continued laboratory accreditation to ISO/IEC 17025:2017 will allow for a complete quality system to ensure defensible analytical results are put forth. The accreditation attests to the competency and technical capabilities of a laboratory to perform certain tasks and supports traceability of data generated. The collaboration between the regulatory programs and the laboratory will play an integral role in achieving an integrated national food safety system.

Public health relevance
Project Narrative By participating in this cooperative agreement, the Kansas Department of Agriculture Laboratory (KDAL) aims to successfully expand the testing capabilities in both Microbiology and Chemistry as well as increase sample throughput in human and animal product testing. Additionally, KDAL will continue with their existing quality system consistent with the principles and requirements of ISO/IEC 17025:2017. The standard will attest to KDAL’s competency and technical capabilities to perform tasks and support traceability of data generated. This cooperative agreement will allow for the enhancement of both human and animal food product surveillance. Moreover, it will strengthen the relationship between the laboratory and the regulatory programs. By expanding the existing surveillance program KDA aims to ensure a safer food supply for Kansas.